Region 7 RML Core

RML Core
Abstract
The University of Massachusetts Medical School (UMMS) aims to connect Network Members
and partners with resources of the NLM and NNLM NER such as: formalized curricula,
Communities of Interest (COI), Focused Health Information Outreach, and opportunities for
technology improvement. Target audiences for education and outreach include health
professionals, the public health workforce, and the general public with a focus on minority and
other underserved and underrepresented populations. The work conducted in the RML Core will
increase awareness of NLM resources among consumers, health professionals, and other
health information providers. UMMS will promote the effective use of information and decision
support resources that hold the promise of promoting healthy behaviors, preventing costly and
debilitating illness, and improving health outcomes.

Public health relevance
Regional Medical Library Core Project Narrative Though community engagement, education, funding, exhibiting, and Member recruitment, Region 7 will work to promote the products and services of the National Library of Medicine and improve health literacy. Collaborating partners include the other Network of the National Library of Medicine Regions, Network Members, libraries, public health organizations, schools, and community-based organizations. Using assessment and evaluation tools, programs and services will be monitored and adjusted to maximize reach and ensure that evidence-based information is being used to improve health outcomes.